Improving anti-tumor immunity in advanced breast cancer by targeting solid stress

Project Summary
Response rates to current immunotherapies are comparably low in breast cancer patients, yet patients with T
cell infiltrates often respond better. To improve the response rates of breast cancer patients to immunotherapy,
it is imperative to develop strategies that enhance T cell infiltration. In a recent study, we demonstrated that
cancer cells compress blood vessels within metastatic breast tumors and impair the recruitment of T cells into
these tumors. Losartan, an antihypertensive and antifibrotic drug, reduced extracellular matrix production in
metastatic breast tumors, normalized blood vessels, and promoted T cell accumulation in tumors. Based on
these findings, we hypothesize that the angiotensin receptor blocker (ARB) losartan decompresses the tumor
vasculature and promotes T cell trafficking into mouse breast cancers. To test this hypothesis, we will use a
lymph node window that allows in vivo imaging for two weeks. With the window, we will use optical coherence
tomography imaging to measure tissue compression and blood vessel function within primary and lymph node
tumors (Aim 1). In addition, we will use multiphoton microscopy imaging and adoptive transfer studies to test our
hypothesis that losartan promotes naïve and cancer specific T cell entry into decompressed vessels in primary
and lymph node tumors (Aims 1 and 2). Further, our experiments are designed to uncover how losartan,
combined with immunotherapy to enhance T cell function, leads to the eradication of breast tumors (Aim 2). We
will use single cell RNA sequencing and flow cytometry to examine the composition and transcriptional
signatures of cells in the reprogrammed tumors responding to combination therapy. Finally, we will test whether
T cells are sufficient for tumor growth delay. Based on preliminary data from animal studies, we hypothesize
that the use of ARBs, such as losartan, by breast cancer patients is associated with reduced extracellular matrix
deposition in tumors and enhanced T cell infiltration into tumors. To study if ARB use is associated with these
predicted outcomes, we will use patient specimens from women enrolled in the Black Women’s Health Study
(BWHS), including those who took ARBs at the time of diagnosis. In Aim 3, we will use multiplex staining and
quantitative multispectral imaging to investigate extracellular matrix deposition, vascular structure, and immune
cell infiltration in 554 invasive breast cancer samples. A bioinformatic analysis of RNA-sequencing data obtained
from invasive breast cancer samples will be performed to investigate transcriptomic signatures associated with
cells in the tumor microenvironment. We will measure whether our findings from ARB-naïve patients and ARB
users strongly associate with survival and other clinicopathological characteristics. We anticipate that successful
completion of the proposed studies by our multidisciplinary team will reveal the clinical utility of ARBs as a
potential strategy to increase T cell entry into breast tumors and improve the disconcerting response rates to
current immunotherapies.

Public health relevance
Project Narrative Our objective is to determine if angiotensin-receptor blockers (ARBs) can enhance T cell infiltration into breast tumors and if this enhancement, when combined with cancer immunotherapy, can effectively reduce breast cancer progression. To accomplish this, we will measure T cell infiltration and function directly in mouse breast cancer models and we will also evaluate human breast cancer tissue samples to explore the potential synergy between ARBs and cancer immunotherapy. This research is of critical importance, considering the alarming annual toll of over 40,000 American lives claimed by breast cancer.